MFRPS Maintenance Pennsylvania Department of Agriculture (PDA)

Project Summary/Abstract
The Pennsylvania Department of Agriculture (PDA) is applying for the Flexible Funding
Model-Infrastructure Development and Maintenance for State Manufactured Food
Regulatory Programs (U2F) Clinical Trials Not Allowed Funding Opportunity for 2023-
2026 (RFA-FD-23-027) to continue conformance and maintenance of the Manufactured
Food Regulatory Program Standards (MFRPS). Under state authority, PDA adopts most
of the specified CFR provisions as the regulations of the Commonwealth of Pennsylvania
which in turn are the regulations by which PDA enforces at manufactured food facilities
throughout the Commonwealth. Inspections are conducted following the best practices
as developed by the Partnership for Food Protection workgroup recommendations for
risk-based inspections. Achieving conformance with the MFRPS was a major
component of the previous 5-year grant cycle and PA continues to build on this previous
work to align with the expectations within the new Funding Opportunity
Announcement. With the continued support through the FFM grant, the Pennsylvania
Department of Agriculture intends to continue and further develop the Manufactured
Foods Program and implement a Food Safety Protection Taskforce in order to develop
outreach materials with resources for academia, industry, and is committed to sharing
these results and materials on a national level in order to foster and support an
integrated food safety system. As a previous recipient of these grant awards, PDA has
shown continued improvement of meeting grant deliverables and will continue to
develop the programs implementing best practices, while participating in information
sharing and mutual reliance to promote an overall national integrated food safety
system.

Public health relevance
MFRPS Maintenance Pennsylvania Department of Agriculture (PDA) With the continued support through the FFM grant, the Pennsylvania Department of Agriculture intends to continue and further develop the Manufactured Foods Program and implement a Food Safety Protection Taskforce in order to develop outreach materials with resources for academia, industry, and is committed to sharing these results and materials on a national level in order to foster and support an integrated food safety system. As a previous recipient of these grant awards, PDA has shown continued improvement of meeting grant deliverables and will continue to develop the programs implementing best practices, while participating in information sharing and mutual reliance to promote a national integrated food safety system.